Hepatitis B virus e antigen in viral persistence

Abstract
Hepatitis B virus (HBV) is one of the most important human pathogens. There are approximately 300 million
chronic HBV carriers in the world, resulting in nearly 1 million deaths every year. Most chronic HBV carriers
acquired the virus from their infected mother early in life. HBV has a very narrow host range, which has greatly
hampered its research. By crossing female hemizygous HBV transgenic mice that carry the 1.3mer overlength
HBV genome to male naïve mice, we had developed a mouse model to study the mechanism of HBV persistence.
We found that the persistence of HBV in mice was dependent on the HBV e antigen (HBeAg) and Kupffer cells,
the resident macrophages of the liver. The requirement of HBeAg for HBV persistence is consistent with the
clinical observation that the HBV persistence in babies is dependent on the HBeAg-positivity of their mothers.
Our recent studies revealed an interesting interplay between HBeAg and hepatic macrophages. This interplay
can either promote the HBV persistence or HBV clearance. In this application, we will continue to study this
interplay between HBeAg and macrophages to understand the mechanism of HBV persistence. We had recently
discovered that HBeAg could reprogram the metabolism of macrophages to promote the oxidative
phosphorylation (OXPHOS). This metabolic reprogramming by HBeAg appears to be important for the
attenuation of pro-inflammatory activities of Kupffer cells. We will therefore continue to study how HBeAg
reprograms the metabolism of macrophages and study the implication of this reprogramming in the anti-HBV
response. Our preliminary results also indicated that the toll-like receptor 4 (TLR4) mediated the effects of HBeAg
on Kupffer cells. Thus, we will also investigate whether TLR4 serves as the receptor of HBeAg and its role in
HBV persistence. Finally, we will determine whether HBeAg by itself is sufficient to promote HBV persistence
and whether HBeAg can train Kupffer cells in utero to promote HBV persistence. Our proposed studies will
provide important information for us to understand the mechanism of HBV persistence and help to improve the
treatments for chronic HBV patients.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus (HBV) is an important human pathogen. There are approximately 300 million people in the world that are chronically infected by this virus, resulting in nearly 1 million deaths every year. The goal of our proposed research is to understand how HBV establishes persistent infection. The knowledge gained from our studies will be important for improving the treatments for chronic HBV patients.